Leveraging video logs as a bridge to pre-exposure prophylaxis (PrEP) with tailored messaging to Black women and their healthcare providers in Texas

Abstract
Achieving the nation’s Ending the HIV (EHE) Epidemic plan goals will require a significant increase in
access to and uptake of pre-exposure prophylaxis (PrEP) among cisgender Black women (CBW). CBW
continue to bear a disproportionate burden of new HIV cases through heterosexual contact, and are far less
likely to use PrEP. These factors magnify the health and social consequences of HIV to CBW. Although PrEP
is available, CBW are among the least likely groups to use it, as only 2% of PrEP-eligible CBW have reported
PrEP use, which amplifies a significant unmet prevention need. In order to increase PrEP use with eligible
CBW, researchers must identify strategies with capacity to build a secure bridge of connection between CBW
and healthcare providers (HCPs) that can withstand formidable barriers to PrEP uptake (i.e. medical mistrust,
HCP bias and stigma). Support by HCPs who are knowledgeable, willing, and comfortable with prescribing and
referring PrEP to CBW is necessary to increase PrEP initiation among CBW. The primary objective of this R34
proposal is to increase willingness for PrEP initiation and PrEP initiation among CBW and increase willingness
to prescribe/refer PrEP to CBW among HCPs in Houston/Harris County, a high priority EHE jurisdiction.
We hypothesize that a video-log (vlog) series-based health communication intervention disseminated
through community health centers (CHCs) and social media will increase PrEP initiation among CBW by
supporting both CBW and HCPs in a way that will foster PrEP access and uptake. Specifically, the
intervention will: 1) increase willingness to access and use PrEP among CBW and 2) increase willingness to
prescribe and refer PrEP to CBW among HCPs. Our team will explore two aims to 1) inform and develop
health messages for Project ROLE with 2023 findings from focus groups with PrEP-eligible CBW and key
informant interviews with HCPs providing care to CBW and 2) assess the feasibility, acceptability, and
preliminary impact of Project ROLE in two real-world settings with a pilot randomized controlled trial (RCT) and
a social media campaign.
The use of two ‘real-world’ settings to evaluate the feasibility and acceptability of this study is highly
innovative. The proposed research is significant because it will connect CBW to PrEP while increasing HCP
willingness to prescribe and refer PrEP to them using health communication that can guide the development of
subsequent vlog-based interventions to address the national EHE plan.

Public health relevance
Project Narrative Pre-exposure prophylaxis (PrEP), a biomedical prevention intervention with proven effectiveness at preventing HIV transmission, is not widely accessed or used by cisgender Black women (CBW) in Houston/Harris County who are at significant risk for HIV through heterosexual sex. We propose to develop an innovative video-log (vlog) series intervention with single sessions that are specific to both CBW and healthcare providers (HCPs) of CBW, and assess its feasibility, acceptability, and preliminary impact through a pilot randomized controlled trial and a social media campaign. The vlog series will leverage relatable, culturally competent, and engaging narratives (i.e. stories) to increase willingness of 1) CBW in the Houston area to access and use PrEP and 2) HCPs in the Houston area to prescribe and refer PrEP to CBW.